INTRATHECAL MONOCLONAL ANTIBODY FRAGMENT MEL-14 F(AB')2 IN LEPTOMENINGEAL TUMORS

The purpose of this study is to determine the safety and maximum tolerated dose of intrathecal monoclonal antibody fragment Mel-14 F(ab')2-I-131.